Modifications of Lipid A with Phospho-Ethanolamine Impacting Polymyxin Resistance

Modifications of Lipid A with Phospho-Ethanolamine Impacting Polymyxin Resistance
Marcelo Sousa
University of Colorado Boulder
Project Summary
Human Cationic AntiMicrobial Peptides (CAMPs) represent a conserved branch of the innate immune system.
CAMPs constitute a first line of defense against bacterial colonization that is particularly important in exposed
tissues and surfaces such as the skin, eyes, airways and lungs. Furthermore, CAMP antibiotics such as colistin
and related polymyxins are a class of essential drugs in clinical use to treat recalcitrant infection with multidrug
resistant Gram-negative bacteria. These include the “urgent threat” pathogens carbapenem resistant
Acinetobacter baumannii, Carbapenem Resistant Enterobacteriaceae (CRE) as well as “serious threat”
pathogens such as Multidrug Resistant (MDR) Pseudomonas aeruginosa. However, these and other Gram-
negative pathogens have acquired mechanisms to attach cationic modifiers such as phosphoethanolamine
(pEtN) to lipid A in the outer membrane of bacteria (the CAMP/colistin target) which result in resistance to the
bactericidal activity of CAMPs and colistin. This is a significant clinical problem with pathogens that produce
persistent infections with high mortality rates. Therefore, development of inhibitors of the enzyme that catalyzes
the Lipid A modification with phosphoethanolamine (pEtN) is a desirable therapeutic strategy that would result
in potentiators of colistin against deadly multidrug resistant pathogens. A pEtN transferase is required for pEtN-
lipid A biosynthesis and colistin resistance. Therefore, this protein is validated target for drug development to
combat colistin resistance. However, the biochemical characterization of pEtN transferase is incomplete.
Furthermore, in vitro activity assays are either currently unavailable or inadequate for quantitative evaluation of
putative inhibitors. This knowledge gap impairs development of colistin adjuvants that could improve the efficacy
of this life-saving antibiotic. We will close this gap with an integrated, collaborative research program to
structurally and functionally characterize pEtN transferases directly responsible for CAMP/colistin resistance,
screen for probes to define inhibitory strategies, and develop a platform to quantitative test impact of target
activity in vitro. Successful completion of this exploratory multidisciplinary program will result in new insights into
the mechanisms of lipid A modification leading to CAMP/colistin resistance and provide a fully characterized
target with validated assays and active site binding probes. This represents a superb platform for future
development of adjuvant drugs that augment the efficacy of colistin in treatment of infections with multidrug
resistant bacteria.

Public health relevance
Modifications of Lipid A with Phospho-Ethanolamine Impacting Polymyxin Resistance Marcelo Sousa University of Colorado Boulder Narrative: Colistin and other polymyxins belong to a class of last resort antibiotics for the treatment of multidrug resistant pathogens. However, Gram-negative bacteria have acquired resistance to this class of antibiotics with an enzyme that chemically modifies their envelope. This proposal is focused on understanding the molecular basis of the resistance mechanism, as a necessary platform to develop inhibitors of resistance that would render the bacteria sensitive to essential “last-resort” antibiotics.